A rapid and inexpensive point of care diagnostic for SARS-CoV-2 infection

Project Summary The project outlines our plans to develop a rapid, point-of-care diagnostic test for the novel SARS-CoV-2 virus that can be used in resource-limited locations. The foundation of the project is a highly selective chemiluminescent reporter probe that produces light when activated by the major viral protease SARS-CoV-2 Mpro. This approach will enable rapid testing (<30 min) of easily obtained clinical samples (i.e., saliva) using a detector that has limited power needs and that can interface with standard smart phones to provide a diagnosis.

Public health relevance
PROJECT NARRATIVE This project outlines plans to develop a rapid, inexpensive point of care diagnostic test for the SARS-CoV-2 virus that can be used in resource limited settings.